Characterization of RHA:RT interactions in HIV-1 reverse transcription

Project Summary
HIV-1 infection is one of the leading causes of death globally. The urgent need for the
development of new antiviral therapies arises from the lack of vaccine and emerging of drug-
resistant strains. HIV-1 reverse transcriptase (RT) is an error-prone polymerase responsible for
the emergence of notorious drug resistant mutants. Due to the low processivity, RT pauses on
certain RNA sequences/structures and the pausing is correlated with high mutation and
recombination rate. The mechanism that maintains fidelity relatively high in the RNA regulatory
regions but error-prone in open reading frames during reverse transcription is poorly understood.
Host helicase DHX9/RNA helicase A (RHA) is recruited into virions and promotes processivity of
RT. Preliminary data suggest dynamic RT: RHA interactions during reverse transcription and
reveal that RHA improves RT’s fidelity on structured regulatory RNA regions. The overall goal of
this proposal is to establish the structural basis for RHA-mediated RT fidelity modulation during
reverse transcription. Aim 1 will characterize the RHA-dependent fidelity enhanced hotspots in
the viral genomic RNA by sequencing the cDNA synthesized in the absence and presence of host
RHA. Aim 2 will characterize the RT:RHA interactions by cryo-EM, and validate by cell-based
assays. The proposed studies will offer insights into the mechanism of the host helicase mediated
modulation of RT pausing and fidelity at various locations of the genomic RNA during reverse
transcription, and provide structural basis for the development of novel antiviral therapies.

Public health relevance
Project Narrative HIV-1 reverse transcriptase (RT) is an error-prone polymerase that is responsible for the emergence of drug resistant mutants. The overarching goal of this proposal is to investigate how host helicase is co-opted to work with RT to maintain the fidelity in the essential RNA regulatory regions in a balance with tolerable variation in open reading frames to increase genetic diversity. The proposed structural and mechanistic studies will advance our understanding of important HIV-1 replication events and help to develop new antiviral strategies.